Simulation Tools for 3D and 4D CT and Dosimetry

Abstract
Photon-counting CT (PCCT) is a major technological advance in CT imaging. Using photon-counting instead of
current energy-integrating detectors, PCCT can offer superior performance in terms of spatial resolution, artifact
reduction, and most notably, material decomposition. PCCT’s energy differentiation utility offers an ability to more
precisely distinguish different materials and optimize and expand the use of contrast agents in CT. With these
abilities, PCCT can significantly facilitate quantitative imaging, reduce radiation exposure, and enable
revolutionary new applications in functional and physiological imaging beyond existing CT techniques.
To realize the full potential of PCCT in clinical practice, the technology needs comprehensive assessments and
application-based optimizations. Effective design and deployment of PCCT depends on many design and use
choices that should be made in view of the eventual clinical utility. Making these choices requires large scale
trials on actual patients. However, such trials are challenging, considering the need to make many decisions
prior to prototyping, the limited numbers of prototype PCCT scanners available today, and the often-unknown
ground-truth in the patient images. Even for existing prototype systems, many decisions require repetitive trials
with multiple acquisitions. This is both unethical and impractical considering radiation safety concerns and costs.
These challenges can be overcome by utilizing virtual imaging trials (VITs) using computerized patients and
imaging models. VITs provide an efficient means with which to determine the most effective and optimized design
and use of imaging technologies with complete control over the study design.
In our prior funded project, we developed a VIT framework to evaluate standard energy-integrating detector CT
technologies. In this project, we expand the applicability of this framework to photon-counting detector CT.
Specifically, we enhance our computational XCAT phantoms to model the necessary higher-resolution detail
including normal and abnormal tissue heterogeneities and intra-organ contrast perfusion diversity across
populations (Aim 1). To image the phantoms, we develop the first PCCT simulator capable of mimicking existing
and emerging prototypes (Aim 2). The enhanced VIT framework will provide the essential foundation with which
to comprehensively evaluate and optimize PCCT technologies and applications. In Aim 3, we assess and
optimize the use of PCCT for morphological, textural, and compositional quantification in select oncologic and
cardiac applications, two leading health detriments in the US where PCCT can offer a notable impact. The results
will be the first of their kind in comprehensively evaluating the task-based merits and capabilities of PCCT,
determining optimum dose per patient size for PCCT imaging of patients for cancerous lesions and cardiac
plaque/stenoses, and helping to establish the effective utility of PCCT in clinical care.

Public health relevance
The purpose of this project is to develop and utilize a virtual framework to comprehensively evaluate and optimize emerging photon-counting devices and applications in CT imaging. The results will be the first of their kind evaluating the task-based merits and capabilities of photon-counting CT and will help establish its effectual utility in oncologic and cardiac care.